Transcription Factor Control of Liver Development and Function

Project Summary
The goal of this proposal is to determine how the FoxO1 transcription factor contributes to human liver
development as a mediator of gene expression and metabolism in the differentiating hepatocyte. This
knowledge will contribute to a more complete understanding of the mechanisms underlying hepatocyte
differentiation and function necessary for tackling pervasive human metabolic disorders, as well as improving
hepatocyte derivation from pluripotent stem cells. FoxO1 is classified as a “pioneer” or initial chromatin binding
transcription factor due to its unique ability to open silent compacted chromatin and perturb underlying
histone:DNA contacts to promote recruitment of additional regulatory factors. We have used a novel human
induced pluripotent stem cell (hiPSC) hepatocyte differentiation system to show, for the first time, that stage-
specific disruption of FoxO1 chromatin binding prevents the establishment of hepatic progenitors within the
definitive endoderm and severely curtails hepatic specification, the first two stages of liver development. This
discovery raises the exciting possibility that FoxO1 obligatorily regulates the network of genes that is required
to specify hepatic fate in the human embryo. Additionally, we've show that, in human hepatocytes,
interdependent chromatin binding by FoxO1 and another liver-enriched pioneer factor, FoxA, plays an
essential role in maintaining an active chromatin environment as well as the binding of transcription factors that
induce insulin-regulated genes. Taken together with a recent study showing that FoxO1 and FoxA co-target
multiple genes linked to metabolic pathways for glucose, lipids, cholesterol, and bile acids, this finding points to
interdependent FoxO1/FoxA binding as a general regulatory mechanism enabling the creation and
maintenance of active chromatin states in response to extracellular cues for a broad array of hepatic metabolic
processes. Based on this evidence, we hypothesize that FoxO1 uses its diverse chromatin binding and
remodeling capabilities to play two distinct roles in human liver development: (1) participation in key
developmental pathways as a transcriptional regulator of target genes required for hepatocyte
specification and differentiation followed by (2) cooperation with FoxA factors to activate and modulate
expression of metabolic genes essential for the mature hepatocyte. We propose to investigate this
hypothesis by identifying the essential gene regulatory networks induced by FoxO1 that are responsible
for specification of human hepatic fate and determining how interdependent FoxO1/FoxA binding and
transcription regulatory factor recruitment impacts their activation of essential hepatic metabolic
functions. Subversion of the corresponding gene regulatory events is a likely contributor to metabolic
derangements and hepatic disease, making it vital that we uncover the key mechanisms and players.

Public health relevance
Project Narrative The overall goal of this proposal is to determine how the FoxO1 transcription factor contributes to human liver development as a mediator of gene expression and metabolism in the developing liver. Inhibition of FoxO1 function obstructs the earliest stages of liver development, while FoxO1 insufficiency is linked to diabetes and other metabolic disorders in the adult. Knowledge gained from the proposed work will contribute to a more complete understanding of the mechanisms underlying liver development and function necessary for tackling pervasive human metabolic disorders and improving hepatocyte derivation from stem cells.